Genetic Approaches to Evaluation of the Roles of Leptospira interrogans Adhesins in Endothelial Interactions

Abstract
Leptospirosis is caused by several pathogenic species of spirochetes of the genus Leptospira
and is the most widespread zoonosis worldwide. Pathogens in the genus Leptospira are
maintained in zoonotic cycles, demanding that they be able to establish persistent,
disseminated infection in immunocompetent host animals, but the genus also includes
saprophytic, non-pathogenic species. Reservoir hosts do not develop severe disease, but the
outcome of the Leptospira-host interaction depends on the host species, the Leptospira species,
serological variant (serovar), and additional unknown factors. Disease in humans ranges from
mild self-limited illness to acute life-threatening infection with kidney failure, and liver
dysfunction, and widespread endothelial damage, increased permeability, and hemorrhage.
Disruption of endothelial barriers is likely to facilitate dissemination and to contribute to
hemorrhagic disease manifestations. We have focused on investigation of interactions between
endothelial cell surface receptors and Leptospira in vitro, identified endothelial cell-surface
receptors for L. interrogans, and identified candidate L. interrogans adhesins (denoted
LIC11574 and LIC13411) that bind to VE-cadherin, the primary endothelial barrier determinant.
We hypothesize that adhesion to host transmembrane receptors by multiple adhesins
contributes to disruption of endothelial barriers and transmigration of the bacteria.
In this proposal, we will take multiple approaches to determining the roles of previously
identified adhesins in bacterial transmigration, disruption of VE-cadherin, and changes in
transendothelial electrical resistance (TEER). We will employ Tn mutants, and gain of function
derivatives of a saprophytic strain that produce VE-cadherin adhesins, to evaluate the potential
roles of 7 adhesins. Innovation lies in use of both genetically modified Leptospira strain sets in
our endothelial cell culture model. In Aim 1 we will characterize the phenotypes of L. interrogans
transposon mutants in genes encoding known or candidate adhesins for adhesion to and
transmigration across endothelial layers. In Aim 2 we will similarly characterize gain of function
saprophytic strains producing L. interrogans adhesins that bind VE-cadherin.
Our proposed work will constitute a major step toward resolving the biologically fundamental
question of what are the functional determinants of Leptospira that separate the pathogens from
the non-pathogens. The proposed work will also take steps toward resolving a long-standing
controversy in the field: Is endothelial damage the result of bacterial interactions with the
endothelium or to the host response, increasing impact.

Public health relevance
Project Narrative Leptospirosis, caused by several pathogenic species of spirochetes of the genus Leptospira, is the most widespread zoonotic disease worldwide. Disease in humans varies from mild self- limited illness to acute life-threatening infection with kidney failure, liver dysfunction, vascular damage and resulting hemorrhage in multiple tissues. Here we will take multiple approaches to determining the roles of previously identified bacterial proteins that mediate attachment to human cells in disruption of vascular barriers, which would contribute not only to spread of the bacteria but also to hemorrhagic disease seen in severe leptospirosis.